Cincinnati Regional Coordinating Center for NINDS Stroke Trial Network

The objectives of the NIH StrokeNET are to harness multidisciplinary stroke expertise to
collaboratively and efficiently conduct exploratory NINDS-sponsored trials in all phases (I, II, III)
and all domains (acute, prevention, recovery). The Cincinnati Regional Coordinating Center
(Cincinnati RCC) is composed of 34 hospitals served by the University of Cincinnati (UC) stroke
team network, and two new satellite networks served by the University of Louisville and
Michigan State University stroke teams. Our goals are to (1) efficiently initiate trials, recruit and
retain participants, and optimize data quality; (2) actively contribute to the overall success of
NIH StrokeNET; and (3) successfully train the next generation of stroke clinical trialists. We will
achieve this by bringing an established research infrastructure, a large and diverse patient
population, experienced leadership, a rich training program, and a supportive administration.
We have been successful as an RCC by all metrics in the prior grant cycle, including rapid trial
initiation, high trial recruitment, high data quality, and consistent StrokeNET participation. Our
sites have shown their commitment to NIH StrokeNET by establishing Master Trial Agreements
and Reliance Agreements for central IRB review. Our department has shown its support by
providing additional funds to complete the RCC trainee's salary and benefits. We are committed
to continued partnership with NIH StrokeNET to advance stroke care for our patients.

Public health relevance
NARRATIVE: Stroke is a public health priority as a leading cause of death and disability worldwide. Multicenter clinical trials are needed to test new discoveries that may reduce this burden in the treatment, prevention, and recovery arenas. The Cincinnati RCC proposes continued partnership with the NIH StrokeNET to improve clinical trial efficiency, success, and quality, and thereby advance stroke care.